USC-Buck Institute Nathan Shock Admin Core

ABSTRACT- Administrative and Program Enrichment Core
The Administrative and Program Enrichment Core (APEC) will provide the infrastructure for USC-Buck NSC,
engaging with researchers across the country, disseminating research findings to the public and biology of
aging research communities, and providing support (mentoring, in-kind services, and direct financial support)
to promote research and develop careers of biology of aging researchers, particularly junior faculty and
postdoctoral scholars, through the activities of the Research Developmental Core (RDC) and access to cutting-
edge technologies in three unique Resource Core (RCs). The APEC's specific aims focus on the following
functions: Oversight and stimulating USC-Buck NSC progress; Sustaining the USC-Buck NSC; Evaluating NSC
progress; and Reporting and disseminating NSC activities and outcomes. To accomplish its Specific Aims, the
APEC has developed an administrative structure with five primary components to accomplish its research and
training activities: Core Administrative Unit; Executive Committee (EC); Pilot and Feasibility Committee (P&FC);
Internal Advisory Board (IAB); and an External Advisory Board (EAB).